IMMUNOLOGIC STUDIES RELATED TO MALIGNANCY

The q23 region of human chromosome 11 will be examined using an immunogenetic approach that utilizes somatic cell hybrids and human cell surface antigens expressed by these hybrids. Monoclonal antibodies recognizing these antigens allow them to be used as selective markers to manipulate the loss and retention of regions of chromosome 11. More than 16 different chromosomal subtypes of leukemia and lymphoma have a rearrangement of 11q23 with a second, but varying chromosome. A malignancy associated translocation in Ewing sarcoma involves 11q23. The most common recurrent constitutional translocation is also in this chromosomal region. Regional somatic cell mapping panels will subdivide 11q23 and pulsed field gel electrophoresis will be used to locate these breakpoints. Isolation of breakpoints and comparison of their sequences will be used to test hypotheses about mechanisms of chromosomal rearrangements. The identification of gene sequences including possible proto-oncogenes should add to the understanding of the pathogenesis of malignancy.